Role of Innate Immunity and Stat3 Activation in Colitis Mouse Model

DESCRIPTION (provided by applicant): Inflammatory bowel disease (IBD), Crohn's disease or ulcerative colitis, affects an estimated 1.4 million Americans and is manifested by chronic inflammation of the gastrointestinal tract with significant morbidity and, at times, life-threatening complications. IBD is proposed to result from a dysregulated mucosal immune (innate and adaptive) response to the colonic flora in genetically susceptible individuals. Bacteroides fragilis is a common human commensal residing in the colon. A subset of B. fragilis, enterotoxigenic B. fragilis (ETBF), has been associated with inflammatory diarrheal disease, IBD, and colorectal cancer. Our ETBF murine model data shows that colonization with ETBF leads to a proinflammatory response exhibiting a predominant Th17 (interleukin 17-secreting) CD4+ T cell infiltrate promoted by signal transducer and activator of transcription-3 (Stat3) in C57BL/6 mice. The presence of activated Stat3 as well as colitis is evident within hours of orogastric inoculation with ETBF. However, there have been no investigations to date regarding the role of the innate immune system in ETBF colitis. IL-17 skewing has been recently demonstrated in a different infectious model involving downstream products of the Nucleotide-binding oligomerization domain containing (NOD) innate immune pathway. There is a strong association of NOD2 gene mutations and Crohn's disease. Hence, this data supports that innate immune factors and signal transducer and activator of transcription 3 (Stat3) plays a major role in the ETBF mouse model of colitis providing insight into the genesis of Inflammatory Bowel Disease. The objective of this research project is to address the role of the innate immune signaling pathways, in particular the NOD/Rip2 and toll like receptor (TLR)/MyD88, in the ETBF-induced colitis model. We will test the hypothesis that MyD88-/- and Rip2-/- mice will exhibit enhanced ETBF-induced colitis and Stat3 activation. To that end, the following Specific Aims are proposed: Specific Aim 1: To evaluate the role of NOD/Rip2 and TLR/MyD88 innate immune pathways in response of ETBF induced colitis using various genetically manipulated mice; Specific Aim 2: To define the role of Stat3 activation in the pathogenesis of ETBF-induced colitis in the NOD/Rip2- and TLR/MyD88- deficient mice; Specific Aim 3: To determine the role of TLR/MyD88 and NOD/Rip2 deficiency in hematopoietic versus non-hematopoietic derived cells on Stat3 activation and the pathogenesis of ETBF-induced colitis by creating and utilizing chimeric mice derived via bone marrow (BM) transplantation. The project will use the murine (C57BL/6) model of ETBF-induced colitis and various immunologic assays, knock-out mice, bone marrow transplantation, immunohistochemistry, flow cytometery, cytokine and RNA analysis. The significance of this research is that it will allow insight into the dysregulated immune response to colonic bacteria associated with IBD, a disorder with substantial morbidity, with hopes for new therapeutic insights to this prevalent disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study examines the role of innate immune system, specifically TLR and NOD receptor signaling pathways, and the role of signal transducer and activator of transcription 3 (Stat3) in a bacteria induced colitis mouse model. Information obtained from this study will allow insight into the dysregulated immune response associated with IBD, a disorder with substantial morbidity. NARRATIVE This study examines the role of innate immune system, specifically TLR and NOD receptor signaling pathways, and the role of signal transducer and activator of transcription 3 (Stat3) in a bacteria induced colitis mouse model. Information obtained from this study will allow insight into into the dysregulated immune response associated with IBD, a disorder with substantial morbidity. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Inflammatory bowel disease (IBD) is postulated to result from a dysregulated adaptive and innate immune response to host microflora in genetically susceptible individuals. Multiple genes of interest have been identified in patients with IBD. The clear relationship between these genes, the dysregulated immune response, and microflora in IBD patients remains unclear. Nucleotide-binding oligomerization domain containing 2 (NOD2) is a protein, also known as the caspase recruitment domain family, member 15 (CARD15), which plays an important role in the immune system. Defects in NOD2 gene have been linked to IBD. The protein encoded by the gene recognizes molecules containing the specific structure called muramyl dipeptide (MDP) that is found in certain bacteria. It plays a role in the immune response to intracellular bacteria. In addition, in genome wide analysis, single nucleotide polymorphisms of the signal transducers and activators of transcription 3 (Stat3) protein has been identified in patients with Crohn's. Stat proteins are transcription factors that once activated play a critical role in regulation of immune responses especially host interactions with bacteria. Although no specific pathogen has been implicated, enteric bacteria appear to play a significant role in disease pathogenesis of IBD. Excessive epithelial permeability in IBD patients enhances direct contact between colonic flora and the immune system possibly serving as a critical factor in disease initiation. Bacteroides fragilis is a common human commensal occupying the colon with high rates of colonization in adults. This bacterium is the leading anaerobe implicated in human disease. B. fragilis exhibits three major molecular classes, of which one, enterotoxigenic Bacteroides fragilis (ETBF), is associated with inflammatory diarrheal disease, inflammatory bowel disease (IBD), and colorectal cancer in human studies. However secondary to high asymptomatic carriage rate, ETBF is associated with a wide spectrum of outcomes including human disease. The primary virulence factor of ETBF is a 20 kDa zinc-dependent metalloprotease toxin termed B. fragilis toxin (BFT) that is secreted by ETBF in vitro and in vivo. Our previous work has focused on studying the commensal and, at times, pathogen ETBF in a murine model and its adaptive immunologic response. ETBF-colonized conventional C57BL/6 mice, typically colitis- resistant mice, develop acute, symptomatic colonic inflammation that evolves into a chronic, yet asymptomatic, colitis. Interestingly, in contrast to the vast majority of other rodent colitis models that exhibit a common Th1 phenotype, ETBF-induced colitis exhibits a predominant Th17 (interleukin 17-secreting) CD4+ T cell infiltrate promoted by Stat3 in C57BL/6 mice. Based on preliminary data from the Arditi laboratory showing increased IL-17 skewing in Rip2-/- (downstream from NOD) mice, we hypothesize that Rip2-deficient mice will have increased ETBF-induced colitis related to increased IL-17 expression. The colitis induced by ETBF-colonized mice can occur before 24 hours post-inoculation but there was been no investigations to date regarding the role of the innate immune system. The objectives of this research project are to address the role of the innate immune signaling pathways, in particular the NOD/Rip2 and TLR/MyD88, in the ETBF-induced colitis model and to test the hypothesis that innate immune factors and signal transducer and activator of transcription 3 (Stat3) plays a major role in this mouse model of colitis providing insight into the genesis of Inflammatory Bowel Disease. Our specific aims and hypotheses are: Specific Aim 1: To evaluate the role of NOD/Rip2 and TLR/MyD88 innate immune pathways in response of ETBF induced colitis using various genetically manipulated mice. Our hypothesis for this aim is that ETBF induces increased epithelial barrier permeability and triggers specific innate immune responses dependent on TLR/MyD88 and NOD/Rip2 signaling which dampen ETBF-induced colitis. Therefore, we hypothesize that MyD88-/- and Rip2-/- mice will exhibit enhanced ETBF-induced colitis. We will test this hypothesis by investigating the following subaims: 13.C.1a. To investigate the role of TLR/MyD88 signaling pathway in ETBF-induced colitis using specific KO mice. 13.C.1b. To investigate the role of the NOD/Rip2 signaling pathways in ETBF-induced colitis model using NOD and Rip2-defifient mice. Specific Aim 2: To define the role of Stat3 activation in the pathogenesis of ETBF-induced colitis in the NOD/Rip2- and TLR/MyD88- deficient mice. Our hypothesis for this aim is that ETBF activation of Stat3 is increased in NOD/Rip2 and MyD88 deficient mice. We will test this hypothesis by investigating the following subaims: 13.D.1a. To determine the role of Stat3 in ETBF-induced colitis in NOD/Rip2-signaling deficient mice. Is Stat3 Activation by ETBF dampened by NOD/Rip2 innate immune signaling pathway? 13.D.1b. To determine the role of Stat3 in ETBF-induced colitis in TLR/MyD88-signaling deficient mice. Is Stat3 Activation by ETBF dampened by TLR/MyD88 innate immune responses? Specific Aim 3: To determine the role of TLR/MyD88 and NOD/Rip2 deficiency in hematopoietic versus non-hematopoietic derived cells on Stat3 activation and the pathogenesis of ETBF-induced colitis by creating and utilizing chimeric mice derived via bone marrow (BM) transplantation. Our hypothesis for this aim is that TLR/MyD88 and/or NOD/Rip2 expression by both hematopoietic lineage cells and non-hematopoietic (i.e. intestinal epithelial cells) cells will likely play an important role in Stat3 activation and ETBF-induced colitis. We will test this hypothesis by investigating the following subaims: 13.E.1a. To create chimeric C57BL6 mice that express MyD88 or Rip2 in BM-derived cells, non- BM-derived cells, both, or neither by BM transplantation using WT and MyD88-/- donor cells and WT and Rip2-/- donor cells. 13.E.1b. To determine the role of TLR/MyD88 and NOD/Rip2 deficiency in hematopoietic or non- hematopoietic cells by investigating these BM chimeric mice in ETBF-induced colitis model. THESE STUDIES WILL: (i) Determine the contribution of TLR/MyD88 pathways in ETBF-induced colitis and Stat3 activation. (ii) Determine the contribution of RIP2 and NOD1/NOD2 pathways in ETBF-induced colitis and Stat3 activation. (iii) Determine the relative contributions of TLR/MyD88 as well as NOD/RIP2 in BM-derived hematopoietic and non-hematopoietic (i.e. epithelial cells) cells in ETBF-induced colitis and Stat3 activation. Rationale, Significance and Implications for Public Health. The innate immune mechanisms responsible for ETBF-induced colitis model are not well-understood. Our proposed experiments exploit novel genotypes to investigate the specific role of TLR/MyD88 and NOD/Rip2 pathways, and use bone marrow transplantation strategies, and adoptive transfer methods to critically test mechanisms by which ETBF-induces colitis and Stat3 activation. These studies will thus improve our understanding of how innate immune defenses contribute to ETBF-induced colitis and will shed important new light on the relationship of innate immunity, Th17/Stat3, and Inflammatory Bowel Disease hopefully eventually leading to new diagnostic techniques and therapies.